NanoRNA-mediated control of gene expression

DESCRIPTION (provided by applicant): Transcription is the first step in gene expression and the step at which most gene regulation occurs. Transcription in all cells is carried out by multi-subunit RNA polymerases (RNAPs) that are conserved in sequence, structure and function from bacteria to humans. Whereas initiation of DNA synthesis by DNA polymerase requires use of a primer, it is widely accepted that the initiation of RNA synthesis by RNAP occurs de novo (i.e. RNAP initiates RNA synthesis using free NTPs alone). The proposed research will challenge this conventional paradigm. Specifically, we will investigate the hypothesis that a significant fraction of transcription does not occur de novo, but rather relies upon use of small ~2-5 nt RNA transcripts that serve as primers to initiate transcription. We refer to these ~2-5 nt RNA transcripts as nanoRNAs. According to our model, the cell balances nanoRNA-primed transcription and de novo transcription to maintain cellular homeostasis. Furthermore, celular perturbations that alter the balance betwen nanoRNA-primed transcription and de novo transcription lead to global alterations in gene expression. Consistent with this model, we have found that increasing the intracellular concentration of nanoRNAs leads to global alterations in gene expression coupled with an apparent increase in the occurrence of nanoRNA-primed transcription. Building on these findings, we propose to use genetic and biochemical approaches in conjunction with high- throughput sequencing to determine how nanoRNA priming can alter gene expression, identify factors that control the nanoRNA content of the cell, and systematically identify nanoRNAs. The proposed research has the potential to redefine our view of a fundamental process that occurs in all living cells (i.e. transcription) and, in parallel, uncover a novel class of regulatory small RNAs, nanoRNAs, that function in all living cells via a novel mode of action.

Public health relevance
PROJECT NARRATIVE The proposed work will investigate the existence of a novel class of regulatory small RNAs, "nanoRNAs", that function via a novel mode of action. Small RNAs have emerged as key regulators of cellular homeostasis as well as numerous developmental pathways and disease processes. Thus, the proposed research will lead to discoveries with important implications for pubic health. __SpecificAimsTextDelimiter__ Transcription is the first step in gene expression and the step at which most gene regulation occurs. Transcription in all cells is carried out by multi-subunit RNA polymerases (RNAPs) that are conserved in sequence, structure and function from bacteria to humans (1, 2). Whereas initiation of DNA synthesis by DNA polymerase requires use of a primer, it is widely accepted that the initiation of RNA synthesis by RNAP occurs ¿de novo¿ (i.e. RNAP initiates RNA synthesis using free NTPs alone). The proposed research will challenge this conventional paradigm. Specifically, we will investigate the hypothesis that a significant fraction of transcription does not occur ¿de novo¿, but rather relies upon use of small ~2-5 nt RNA transcripts that serve as primers to initiate transcription. We refer to these ~2-5 nt RNA transcripts as “nanoRNAs” (3). According to our model, the cell balances nanoRNA-primed transcription and de novo transcription to maintain cellular homeostasis. Furthermore, cellular perturbations that alter the balance between nanoRNA-primed transcription and de novo transcription lead to global alterations in gene expression. Our studies may transform our view of the transcription process and uncover an entirely new class of regulatory RNAs, “nanoRNAs”, that function in all living cells. RATIONALE It is accepted dogma that all transcription in living cells occurs de novo. However, abundant in vitro evidence indicates that both eukaryotic and prokaryotic RNAPs can utilize small RNA oligomers ranging in length from ~2-5 nt to prime transcription initiation (4-7). Thus, it is reasonable to assume that ~2-5 nt RNA oligomers, “nanoRNAs” (3), can also prime transcription initiation in living cells. Nevertheless, the possibility that a significant fraction of cellular transcription is primed has not previously been investigated. Given the likely abundance of ~2-5 nt nanoRNAs, which, for example, could be generated as end products of RNA degradation or during the process of abortive transcription initiation (see below), we sought to investigate whether priming of transcription by nanoRNAs contributes to gene expression on a global scale. To do this, we genetically engineered a strain of the model Gram-negative bacterium Pseudomonas aeruginosa in order to manipulate the intracellular concentration of nanoRNAs (see Preliminary studies). We found that increasing the concentration of nanoRNAs in P. aeruginosa causes significant alterations in the expression of ~20% of all annotated genes. Furthermore, analysis of primary transcripts isolated from cells containing increased concentrations of nanoRNAs suggests that many of these transcripts were in fact generated by nanoRNA-primed transcription initiation. Our preliminary studies suggest that the balance between nanoRNA-primed transcription and de novo transcription is a critical determinant of cellular homeostasis and, furthermore, that cellular perturbations that alter the balance between primed transcription and de novo transcription lead to global alterations in gene expression. Building on these studies, we propose to investigate the contribution of nanoRNA-primed transcription to gene expression by defining the mechanism by which nanoRNA-dependent priming can alter gene expression, identifying factors that regulate the nanoRNA content of the cell, and performing a systematic identification of nanoRNAs. The proposed research seeks to challenge the conventional paradigm that all cellular transcription occurs de novo. In addition, these studies may lead to the identification of a new class of regulatory small RNA, “nanoRNAs”, that function via a novel mode of action, i.e. through direct incorporation into a nascent RNA transcript (rather than through base pairing with a target RNA transcript). As such, our findings may have significant impact, by redefining our view of a fundamental process that occurs in all living cells and identifying a novel class of regulatory small RNAs that exists in all living cells.